Robust Multivariate Methods for Analyzing Pathway Interactions and Pathway-Phenotype Associations in Bulk and Single-Cell RNA-seq Studies

Abstract
Gene pathway analysis is a critical tool for understanding how groups of genes within biological pathways
collectively contribute to complex human traits and diseases. Widely applied in both bulk and single-cell RNA-
seq (scRNA-seq) studies, these methods have provided valuable insights into molecular processes and their
effects on health. Despite the development of hundreds of pathway analysis tools, recent studies have exposed
significant challenges that undermine the reliability of these approaches. For instance, substantial discrepancies
between gene pathway scoring methods lead to inconsistencies in pathway network construction and cell type
clustering, with false-positive rates in GSEA methods reaching as high as 40%. These issues create uncer-
tainty for researchers in selecting appropriate tools for real-world applications, and attempts to establish a “gold
standard” have proven computationally intensive and context-dependent.
This project proposes a transformative framework to address these challenges. First, we introduce a latent-
factor-based top-down model for unsupervised pathway interaction analysis, designed to efficiently capture
population-specific variations while remaining robust to differences in pathway activity scoring algorithms. Sec-
ond, we propose a set of multivariable latent factor regression models to identify pathway-phenotype associa-
tions. These models enhance statistical power by leveraging individual gene expression data and accounting
for pathway correlations, reducing false discoveries. Finally, we will apply these methods to extensive bulk- and
single-cell RNA-seq datasets to validate existing findings, generate new insights, and tackle complex biological
questions that have previously been out of reach.

Public health relevance
Project Narrative This project aims to address critical challenges in gene pathway analysis by developing innovative statistical models for both unsupervised and supervised analysis. We propose a latent-factor-based model to capture path- way interactions while remaining robust to algorithmic variations, and a set of multivariable regression models to identify pathway-phenotype associations, reducing false discoveries. These models will be applied to bulk- and single-cell RNA-seq datasets to unlock new insights into gene pathway regulation and disease mechanisms. By improving the accuracy and reliability of pathway analysis, this project will enhance our understanding of the genetic basis of complex diseases, ultimately contributing to better diagnostic and therapeutic strategies in public health.